The MobileToolbox for Monitoring Cognitive Function - Admin Core

Administrative Core Summary
The MobileToolbox Administrative (Admin) Core will provide overall administrative and organizational
oversight and management to insure the effective and efficient support of the MobileToolbox initiative. This
will include supporting the financial, organizational, communication and logistical needs of the Steering
Committee, sub-committees, Cores and project. The Admin Core will facilitate communication and continuous
feedback among all MTB components, investigators, and the Steering Committee using multiple
communication modalities, including regularly scheduled meetings The Admin Core will establish and
implement administrative, statistical and technical support structures to enable any needed measure
modification and development, and insure the efficient collection, analysis and storage of data.
The Admin Core will oversee legal and regulatory compliance, including data security, establishing and
implementing mechanisms to protect intellectual property (IP), and maintaining and documenting regulatory
compliance. The core will work collaboratively with the Technology Core and the Data and Statistical
Analysis Core to monitor data security and backup across all data collection sites.
The Admin Core will train and provide resources to the sites to insure successful data collection, using
standardized procedures and continuous site support and offer in-person training utilizing didactics,
simulations/role playing, demonstrations with hands-on practice, reviews, feedback, and discussions. They
will visit sites annually to certify that local data collection is appropriate and consistent across all of the s ites
and provide sites with continuous support for technological and operational issues as well as score
interpretation.